Gating and Permeation in Ionotropic Glutamate Receptors

Our long-term goal is to address molecular determinants of brain disorders. Fast synaptic
transmission in the brain is mediated by ion channels that are directly activated by a chemical
neurotransmitter. NMDA and AMPA receptors are glutamate-gated ion channels that convert the
presynaptic release of glutamate, the predominant excitatory neurotransmitter in the brain, into a
postsynaptic signal. By defining the operation of NMDA and AMPA receptors, we will gain a better
understanding of how they control brain function. We will also learn how to modulate their function
with greater precision and specificity to help understand, and potentially treat, brain disroders such as
schizophrenia, epilepsy, and the excitotoxicity associated with acute and chronic brain disorders.
Our experiments will focus on a eukaryotic transmembrane segment, the M4 segment, which is
positioned around the pore domain. Recent published and preliminary data from our lab has indicated
that the M4 segments act in novel ways to regulate core synaptic functions of NMDA and AMPA
receptors. Highlighting their significance is that inherited and de novo mutations in the M4 segments
induce neurodevelopmental disorders and epileptic encephalopathies. Aim 1 will address the novel
hypothesis that the unique kinetics of NMDA receptors at synapses are due to two kinetically distinct
gates and that the M4 segments regulate these gates in a subunit-specific manner. We will address
this hypothesis using cysteine cross-linking, rigorous single channel analysis, and molecular dynamic
simulations. Aim 2 will address the hypothesis that the M4 segments in NMDA receptors are a major
allosteric conduit coupling external domains to transmembrane and internal domains. Here, we will
test this hypothesis by decoupling external domains from transmembrane and internal domains and
assay this decoupling using electrophysiological and FRET based measurements. Aim 3 will address
the hypothesis that the M4 segments in AMPA receptors carry out distinct functional roles including
acting as a conduit for auxiliary proteins found at synapses. Here, we will compare functional
properties between the M4 segments in NMDA and AMPA receptors using electrophysiological
recordings and molecular dynamic simulations. Our experiments will delineate molecular features of
NMDA and AMPA receptors that contribute to synaptic function. This information will aid in
developing specific therapies to target these receptors in nervous system disorders.

Public health relevance
Neurodevelopmental disorders such as autism and epilepsy and the cell death associated with acute (stroke) and chronic (Alzheimer’s Disease) brain disorders have a devasting impact on human lives and society. Our experiments will address the operation of NMDA and AMPA receptors, glutamate-gated ion channels found throughout the nervous system. The outcome of our experiments will aid in defining how these receptors contribute to devasting brain disorders and how to selectively target them in the clinic.